Sperm tsRNAs/rsRNAs and their RNA modifications in diet-induced epigenetic inheritance

Project summary:
Increasing lines of evidence in mammals have shown that certain acquired traits during paternal environmental
exposure (e.g., unhealthy diet) can be “memorized” in sperm and transmitted to the future generations without
altering the DNA sequence. Our research seeks to unravel the epigenetic mechanisms by which paternal
environmental factors, like diet, are encoded in sperm RNA and influence offspring health. Building on our
discovery of tRNA-derived small RNAs (tsRNAs) and rRNA-derived small RNAs (rsRNAs) in sperm and their
role in intergenerational inheritance, we have raised the concept of 'sperm RNA code'—an RNA
expression/modification signature—that is sensitive to paternal experiences such as diet and stress. However,
the mechanisms by which sperm tsRNAs/rsRNAs and their modifications impact offspring by penetrating the
embryo development process remain largely unknown and await to be addressed. This renewal of our NIH R01
project aims to advance the study of epigenetic inheritance via sperm RNAs, which will extend from our
innovative tools developed from the last funding period, including PANDORA-seq, which uncovers modified
tsRNA/rsRNA that are previously undetectable; and MLC-seq, a novel mass spectrometry-based method to map
multiple RNA modifications of tsRNAs/rsRNAs. We’ll use these new tools to uncover the alterations of
tsRNAs/rsRNAs and their RNA modification under high-fat diet (HFD), and how they regulate offspring
phenotype via early embryonic events such as lineage differentiation. Our preliminary data reveal that tsRNAs
and rsRNAs are uniquely expressed in sperm heads, and that some of them are regulators of cell lineage
differentiation in mouse embryonic stem cells, leading to the hypothesis that they can skew the embryonic lineage
balance between the inner-cell mass (ICM) and trophectoderm (TE), thus a mechanism for influencing balanced
fetus-placenta development. We will systematically explore this potential mechanism by 1) leverage PANDORA-
seq and MLC-seq to identify the modified sperm tsRNAs/rsRNAs responsive to HFD and to examine their roles
by zygotic RNA injection regarding regulations on embryonic cell fate decisions and subsequent fetus:placenta
development; 2) quantify the relationship between dysregulated fetus-placenta weight ratio during mid- and late-
pregnancy to metabolic phenotypes in offspring in a sex-specific manner. 3) Investigate the molecular interplay
of tsRNAs/rsRNAs with nuclear ribonucleoproteins, providing insights into how these interactions may regulate
ribosomal function and translational specificity and thus, embryonic cell lineage outcomes. Collectively, this
research strives to dissect the complex cellular mechanisms underpinning paternal environmental exposure-
induced epigenetic inheritance. It aims to establish deeper insight in understanding the cellar and developmental
origin of sperm RNA-induced epigenetic inheritance upon paternal environmental exposure.

Public health relevance
Project Narrative: Increasing evidence reveals that unhealthy diet induced metabolic disorders in mammals can be transmitted from father to offspring via sperm RNAs. Understanding of how sperm RNA and their modifications regulate offspring health through embryo development would potentially guide interventions to mitigate the risk of transgenerational transmission of diet-related disorders.